Developing Cross-Sector Collaborations to Meet the Social Needs of Veterans

A VA HSR&D-funded multi-stakeholder workgroup identified ways in which research could support the VA’s goal
of addressing Veterans’ unmet social needs. The workgroup identified the siloed nature of VA, the lack of
effective models for finding and connecting VA patients with non-VA social services, and insufficient evidence
on the health impact of healthcare-based social needs interventions as three barriers that could be addressed
by research. This mixed methods pilot study will begin to address these gaps by building partnerships between
the research team, relevant VA program offices, and an organization that has been developing multi-sector
networks to increase Veteran access to health and social services since 2015. Through their AmericaServes
Initiative, the Institute for Veterans and Military Families (IVMF) builds coordinated networks of public and private
organizations to support Veterans. Their breadth of services, wraparound care coordination approach, and
military-centric focus make AmericaServes a promising collaborative for VA medical facilities to join to increase
Veteran access to non-VA social services. Despite the potential benefits, preliminary analyses of AmericaServes
client data and communication with IVMF, the Veterans Experience Office, and other VA program offices,
indicate wide variation in whether and how VA medical facilities participate in AmericaServes Networks or similar
collaboratives. The impact of such participation on Veteran health-related outcomes is also unknown.
The overall objective of this research is to grow the evidence base needed to guide participation of VA medical
facilities in collaboratives such as AmericaServes. As a critical first step, this project will identify how VA medical
facilities currently participate in AmericaServes Networks and factors that impede or facilitate collaboration
across organizations. The project will also establish link AmericaServes and VA administrative data to identify
areas of opportunity for increased collaboration and lay the groundwork for determining the impact of such
collaboration on Veteran health-related outcomes in future studies. The project has three specific aims.
Aim 1 is to characterize the level of, as well as the barriers to and facilitators of, formal and informal
participation of VA medical facilities in AmericaServes Networks. Guided by Himmelman’s Developmental
Continuum of Change Strategies for inter-organizational collaboration, the team will conduct semi-structured
interviews with key informants from a sample of AmericaServes Networks and VA medical facilities. Rapid
qualitative analysis will be used to compare the barriers to and facilitators of different levels of participation.
Aim 2 is to identify the number, percentage, and characteristics of AmericaServes clients who also
receive services from VA medical facilities. AmericaServes data on all 2019 AmericaServes clients will be
merged with sociodemographic and clinical data from VA administrative data sources to identify Veterans served
by both organizations. Demographic, clinical, and service utilization characteristics of Veterans in the overlapping
group will be compared with Veterans served only by VA or only by AmericaServes.
Aim 3 is to develop stakeholder-informed recommendations to guide participation of VA medical
facilities in community-based social service networks (e.g., AmericaServes). Joint displays will be used to
integrate and summarize findings from the qualitative (Aim 1) and quantitative (Aim 2) analyses of VA
participation in AmericaServes Networks. Findings will be discussed with a Stakeholder Engagement Panel
including representatives from IVMF, VA program offices, and Veterans from Community Veteran Engagement
Boards. These discussions will be used to identify areas of opportunity for increased collaboration across
organizations and to develop recommendations to guide future participation of VA medical facilities in community-
based social service networks. The partnerships, findings, and recommendations from this pilot study will inform
future observational and experimental studies examining the impact of working with community-based social
service networks to connect Veterans in VA medical facilities to non-VA social services on Veteran health.

Public health relevance
The proposed pilot study will begin to grow the evidence base needed to guide participation of VA medical facilities in community-based social service collaboratives to link Veterans with non-VA services to address unmet social needs. As a critical first step, this project will identify how VA medical facilities currently work with one successful collaborative, AmericaServes, and factors that impede or facilitate collaboration. This project will also establish an approach for linking and analyzing AmericaServes and VA administrative data to identify areas of opportunity for increased collaboration and to lay the groundwork for determining the impact of such collaboration on Veteran health-related outcomes in future studies. Building on the partnerships, findings, and recommendations established through this pilot work, the program of research ignited by this study will help the VA meet its mission to address unmet social needs among vulnerable Veteran populations by strengthening VA-community collaborations.